Mammalian Fertilization: Identifying the second sperm factor that induces residual calcium oscillations and its contributions to egg activation

There is a persistent gap in our knowledge of the sperm molecules and mechanisms that induce Ca2+
oscillations in mammalian eggs. Ca2+ release triggers egg activation and initiation of embryo development
in all mammals, including human beings. A sperm molecule, the sperm factor, SF, later identified as
Phospholipase zeta, PLCz, was thought to be the only SF responsible for inducing Ca2+ release, and
PLCz inactivating mutations cause infertility in human males. However, Plcz knockout mice are subfertile
and evoke residual Ca2+ oscillations, suggesting the function of a backup mechanism. The component(s)
and the physiological role of the backup system are gaps in our knowledge. These gaps represent serious
impediments, as until we overcome them, we do not understand the Ca2+ regulation of egg activation
events or can objectively diagnose, prevent or treat infertility associated with egg activation failure. The
long-term goal is to understand the molecular basis of the Ca2+ oscillations that unfold the developmental
program at fertilization. The objective is to identify the sperm molecules that trigger these Ca2+ oscillations
in the egg. The mouse and its gametes are perfect models because they are amenable to manipulation
and genetic modifications. The central hypothesis underpinning this proposal is that one or more sperm
PLCs besides PLCz contribute to delivering the Ca2+ signal and could serve as the backup mechanism
in case of Plcz disfunction. This hypothesis was conceived based on extensive preliminary data. The
rationale for the proposed research is that once all sperm molecules that induce oscillations are known,
their regulation assessed, and their diagnostic value and application to the reproductive management of
species fully explored. We plan to test our central hypothesis by pursuing the following specific aims: 1)
Identify the molecule(s) in PLC1z-KO sperm that induce Ca2+ oscillations at fertilization; 2) Determine the
contribution of the backup system to the Ca2+ responses and egg activation events of typical fertilization.
Under Aim 1, we will use Trim-21 mRNA, specific antibodies, CRISPR-generated KO mouse lines,
immunofluorescence, Ca2+ monitoring, and embryo culture to determine if PLCd4 is the active factor of
the backup system. Under Aim 2, we will employ similar methods but target different molecules and
mechanisms to ascertain the contribution of the Ca2+ backup system to the Ca2+ signal of typical
fertilization. The research in this application is innovative because it represents a fresh examination of
the role of other sperm PLCs, including one whose deletion causes male infertility, in the oscillations of
fertilization. The contributions of the proposed project are significant because we aim to perfect the
treatment of egg activation failure, improve embryo development, discover indicators of male fertility, and
identify novel targets of contraception. Finally, we anticipate progress in understanding the molecules
and regulatory mechanisms that induce embryo development in mammals.

Public health relevance
The proposed project is relevant to public health because it will identify the sperm factors that induce the Ca2+ release required for egg activation and initiation of development in mammals. Approximately a third of all cases of human infertility is associated with a male condition, and the molecules studied here underlie male infertility, and identifying their function will improve the treatment of infertile patients. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge that will enhance health and reduce the burden of disease.